Core 1

PROJECT SUMMARY—Data Collection and Clinical Genetics Core
The Program entitled “Genetic Variation in Cancer Risk and Outcomes in African Americans” comprises three
Research Projects and two Shared Resource Core components (Administration, and Data Collection and Clinical
Genetics). The Data Collection and Clinical Genetics Core provides a shared platform for the identification of
eligible Detroit Research on Cancer Survivors (ROCS) study participants for all Projects, provides existing ROCS
data for all projects, supports large scale recruitment and data collection for Project 2 using the ROCS framework,
collects new and manages existing biospecimens for sequencing and genotyping including quality control on
returned genetic data, and links patient data to the Metropolitan Detroit Cancer Surveillance System (MDCSS)
cancer registry for clinical cancer data, the occurrence of multiple primary cancers and recurrence/survival
outcomes. The Core will ensure consistency in the use of previously collected data and biospecimens and
reliability in incorporating/linking these data with newly collected, Project-specific survey and genetic data and
biospecimens across the three projects and four participating institutions. The Core will also provide access to
clinical genetics testing services for those participants who, based on research-based testing, carry clinically
actionable mutations or are included in Project 3. With these resources, we have the opportunity to address
genetic variation in a population-based study of African Americans with cancer and improve uptake of genetic
testing that will ultimately lead to improved outcomes and a reduction in cancer disparities.

Public health relevance
PROJECT NARRATIVE—Data Collection and Clinical Genetics Core The Data Collection and Clinical Genetics Core serves as a hub in support of data and biospecimen collection across multiple projects aimed at understanding the role of inherited susceptibility to cancer in African Americans and improving access to genetic counseling and testing services in this population. It also extends participation in research by providing clinical genetic testing based on research findings.